Intestinal Microbial Communities and Metabolites Changes Associated with Long-term Stress Induced Inflammatory Bowel Disease

Intestinal Microbial Communities and Metabolites Changes Associated with Long-term Stress Induced
Inflammatory Bowel Disease
PROJECT SUMMARY/ABSTRACT
The intestinal microbiome of a host plays an important role in the growth and development of the host. This
research investigates the Gut-Brain-Microbiota Axis (GBMAx) and its role in the complex relationship between
Inflammatory Bowel Disease (IBD) and stress. Recent studies emphasize the gut microbiome's influence on host
behavior and immune system support. Disruptions in the gut microbiome can lead to stress-induced chronic
diseases like IBD and Type 2 diabetes. However, the exact nature of these alterations and their impact on host
health and recovery remains unclear. Therefore, the goal of our study is to determine the role of stress-
induced altered GBMAx in the development of IBD. The hypothesis is that stressed voles' intestinal
microbiome will exhibit a composition and metabolites associated with adverse health outcomes, making them
more susceptible to IBD. The study aims to understand how prolonged social isolation and IBD induction affect
the gut microbiome of prairie voles (PV). Preliminary findings indicate differences in microbial markers associated
with stress and colitis. Unraveling these interactions could provide insights into potential interventions
for individuals with IBD or facing physiological stress. This study will elucidate the interplay of chronic stress,
altered exploration, and anxiety-relevant behaviors which lead to changes in the gut microbiome ultimately
causing IBD. Additionally, it enhances our understanding of specific bacterial community members related to
stress, anxiety, and chronic systemic diseases. The research will engage graduate and undergraduate students,
providing them with valuable hands-on experience. The broader impact includes identifying microbial markers
linked to better health, diet interventions, and insights into the effects of social isolation on mental, and digestive
health.

Public health relevance
Project Narrative This research project delves into the complex interactions within the Gut-Brain-Microbiota Axis (GBMAx) and its role in the development of Inflammatory Bowel Disease (IBD). By examining male and female prairie voles, this research will unravel the consequences of social isolation and physiological stress on the gut microbiome, colon tissues, and behavioral responses, ultimately unraveling the intricate interplay of these factors and their role in IBD while offering insights into the human experience of IBD through GBMAx alterations. Therefore, these findings will not only contribute to a deeper understanding of IBD but also shed light on potential interventions to mitigate its impact, offering insights that extend beyond gut health.